Pilot Research Project Core

ABSTRACT- PILOT RESEARCH PROJECT CORE
We are establishing a Pilot Research Project Core (Pilot Core) as part of our Center with the overarching goal
of building a pipeline of investigators with the skills and experience to conduct high quality, cutting edge, and/or
rapid response research in substance abuse and prevention. We will do so through three aims: (1) Administer
the selection of and supervise the execution of research pilot studies that utilize biomarkers in substance
abuse and prevention research; (2) Enhance the quality of substance abuse and prevention research among
students and fellows, new and early stage investigators, and established investigators who do not have
expertise in drug biomarkers; and (3) Support substance abuse and prevention research among
underrepresented racial/ethnic minority faculty across the United States.
To accomplish Aim 1, the Pilot Core will utilize UCSF's Resource Allocation Program (RAP) for grant
solicitation, submission and review. The Pilot Core will fund at least one innovative pilot project annually. For
Aim 2, the Pilot Core will provide postdoctoral fellows, new and early stage investigators, and established
investigators who do not have expertise in substance use or drug biomarkers with assistance on sample
collection, study design, and data analysis, along with other services related to conducting drug studies in
humans. Finally, for Aims 3, the Pilot Core will leverage UCSF's Learning for Early Careers in Addiction &
Diversity (LEAD) Program to support substance abuse and prevention research among underrepresented
racial/ethnic minority faculty from universities across the U.S. through analytical chemistry support on their
LEAD-funded projects.
These three aims will advance the field of substance abuse and prevention research by facilitating the conduct
of pilot studies to spur larger projects, supporting researchers who do not yet have experience or expertise in
drug biomarkers, and supporting the training of underrepresented racial/ethnic minority faculty researchers in
the field of substance abuse and prevention research.